FACTORS AFFECTING INTERINDIVIDUAL RESPONSIVENESS TO DRUGS

To test the hypothesis that elderly subjects that have genetic deficiency in one route of metabolism are at particular risk for concentration dependent adverse effects due to a further age dependent loss of drug metabolizing ability in an alternative pathway.